NITRIC OXIDE AND BRONCHOPULMONARY DYSPLASIA

The hypotheses of this study is that inhaled Nitric Oxide (INO) will be effective and safe in decreasing the severity of Bronchopulmonary Dyplasia (BPD) in preterm infants. The factors involved in the pathogenesis of BPD include oxidative stress and abnormalities of the surfactant proteins, the family of insulin-like growth factors (IGF's), and the elastin component of connective tissue.